Training in Tropical and Emerging Global Diseases - Supplement

# # ! # $$$ !# # % % '#$%* #
%# $ #&% $%& %$ ! $% % # $ #$ % ! % #$# $ %$%$
( $%&* !#$% $$$ % %)% % #$# !# # $ $ & %
$%$ % !# % + % !#$%$ %# %#% (% %# $%$
'#%#% '% #$ % $ &%% $ (% !#$!%'$ %
$ !! #%& %$ # % %# % !#$% $$$ $ !#$!%'$
# # & #$% )!# * %# #$ #% #$ # & % ( # '#* *#
!# % + % !#$% $$$ & $ # #$! $ # # % %$
* $ # $$ $'# #%* & #$ $ $$ $&% #%*
& % # % $ $ & "& * ! $% $ %# # & # % )% #%
!#$% * %# ! $$ #$##$ % $ % %# $$ %# %#
' ! % %# # # ! # $$$ (% $ %
!#!$ % #$% & # !#$% * #$# #% #$ % %% %' * '# %
& &% !#$% $$$ ' %% % #% & %&# &# !# # $% %# $
(% % %* % %# $ % $ $ % $ % % ' ! % % ! %%
%#' % $ $%# %# %* % %* # & % & % #$# "&$% &%
% %)% !#$% $$ %$ &# % $% & !# % !# # $ &#%# # (
&#$ $ % $%& %$ ! $% $ !#%!% & # %'%$ % # % %#
!#!#% # %# &%&# $&$$ $ ##$ % $%%&% % % # #%
!$% )!# $ % # %# $ # # + '%' #&%
##&% % & # ( '#$%* %%'$ &#%# $%# % %$ * $&$$& %#
!# # # % )% & !# ( %# & & ( #"&# %$ #
! $% %# $ # # # &$ %# ( %# #$ ( ! $% ##&% % $%#%$ %
#$ '#$%* ( $%#%$ % ##&% & ##!#$ % #%$ ! % % )! $ %
!# # (% % &$ % %# $ ( % $ # % %# $ # %
!&%# $

Public health relevance
Parasitic diseases are responsible for millions of deaths in addition to severe and subtly morbidity and there are no effective vaccines or drug treatments to combat them. Understanding how parasites cause disease requires researchers and practitioners with high level of training. The Training in Tropical and Emerging Global Diseases program offers advanced training and professional development of talented predoctoral and postdoctoral trainees to prepare them for careers dedicated to fighting parasite pathogens.